Career Enhancement Core

Project Summary. FDA’s tobacco regulatory authority calls for an evidence-based approach that emphasizes
protecting public health. This approach differs from pharmaceutical regulation and thus requires differently
trained regulatory scientists. The Career Enhancement Core (CEC) continues and expands the Center for the
Study of Tobacco Products’ (CSTP’s) program of tobacco regulatory science and research training designed to
meet FDA and NIH needs. The CEC offers an updated graduate course on tobacco regulatory science,
educates pre- and post-doctoral appointees, engages investigators new to tobacco regulation, and, at no
added cost to NIH, integrates tobacco regulatory science into two existing international programs that train
scientists and policymakers. The specific aims of the CSTP’s CEC are to: (1) conduct a transdisciplinary
graduate course and produce methods-based webinars, (2) educate pre-doctoral and post-doctoral
appointees, (3) engage non-CSTP faculty in tobacco regulatory science, (4) create a pilot research program,
and (5) integrate tobacco regulatory science into ongoing international training programs.
In sum, the CSTP proposes a Career Enhancement Core that will continue to teach tobacco regulatory science
and transdisciplinary methods for tobacco product evaluation, support pre-doctoral and post-doctoral
appointees, and engage new investigators in tobacco regulatory science. The pilot research program will help
appointees learn proposal writing and management skills while fostering collaborations between CSTP faculty
and investigators new to tobacco regulatory science. Taken together, all of these activities support the U54-
funded CSTP and will build on the CSTP’s history of producing an experienced cadre of tobacco regulatory
scientists ready for productive careers in academia, government, and other areas.